The Center for Biomolecular Structure at NSLS-II

Abstract - Overall Core
Brookhaven National Laboratory has developed a world-leading suite of experimental facilities for the life-
science research community. Much of it is organized in the Center for Biomolecular Structure (CBMS), which
has a focus on macromolecular crystallography (MX) and x-ray scattering, with a user program of imaging in
biological materials: fluorescence imaging of metals, and full-field absorption and phase-contrast imaging on all
materials. We exploit the unprecedentedly small, bright, and well-collimated x-ray beams of National
Synchrotron Light Source II (NSLS-II) with experimental stations that provide the best possible crystal-
diffraction and x-ray scattering data with high levels of automation. Our responsibility to the users is to enable
hypothesis-driven research by having sufficient throughput to support high-volume systematic studies, and with
the capability, through our assembly of diverse beamlines, to support multi-disciplinary work for complex
investigations.

Public health relevance
Project Narrative - Overall Core The Center for Biomolecular Structure (CBMS) presents state-of-the-art structural biology facilities at the National Synchrotron Light Source II (NSLS-II) to the world-wide community of researchers interested in the study of biological structure. These facilities include 1. micro-beam and highly automated macromolecular crystallography, 2. several modes of x-ray scattering from non-crystalline material, including from solutions, scattering images from tissues, and others, and 3. imaging by x-ray fluorescence at a range of energies and resolution scales, and full-field imaging.